Resting state MRI to map autoregulation of the kidney

Project Summary/Abstract
The kidney maintains glomerular filtration, despite constant and potentially damaging natural fluctuations in
systemic blood pressure. This autoregulation is critical to maintaining the structural and functional integrity of
the kidney, and failure of autoregulation is strongly implicated in progression of kidney pathologies associated
with diabetic and hypertensive nephropathy. There are several identified mechanisms of autoregulation of local
blood pressure and flow, including a myogenic response and tubuloglomerular feedback (TGF). These
mechanisms are associated with distinct bands of low frequencies of oscillation in perfusion pressure, but there
are currently no tools to investigate the spatial localization of these mechanisms or develop them for potential
clinical use. Here we develop the tool of resting- state magnetic resonance imaging (MRI) to measure and map
oscillations in vascular diameters associated with these two mechanisms. This is based on our recent
observations of reproducible resting- state fluctuations in MRI with frequency bands consistent with myogenic
and TGF mechanisms. We will first investigate this tool in the healthy rat kidney and measure patterns in the
spectra within and between kidneys during the life course of the animal. We will validate the MRI
measurements using optical microscopy, and determine whether the detected autoregulation is eliminated or
reduced with administration of furosemide. Finally, we will investigate the use of resting- state MRI to measure
a decrease in autoregulation during development of nephropathy in the spontaneously hypertensive rat model.
If successful, this work will provide a noninvasive tool to more completely understand mechanisms and
develop predictive markers to investigate genetic models, guide new therapies, inform allograft transplantation,
and monitor kidney health.

Public health relevance
Project Narrative Autoregulation is critical to maintain stable kidney function in the presence of natural, potentially damaging changes in blood pressure. Measuring autoregulation is critical to understanding and developing therapies for kidney diseases associated with diabetes and hypertension. We will develop and test a new, safe tool to measure and map autoregulatory mechanisms of the kidney using magnetic resonance imaging (MRI).